The impact of the gut microbiome on rheumatoid arthritis treatment

PROJECT ABSTRACT
Rheumatoid arthritis (RA) is an inflammatory arthritis resulting in irreversible damage unless effective
therapy is provided quickly. Oral methotrexate (MTX) is first-line therapy for RA but is inadequate in 50-70% of
patients; clinicians currently employ a “trial and error” approach to treatment. While many have studied whether
human genetics or environmental factors predict MTX response, none have examined the role of the gut
microbiome. We recently showed that the gut microbiome of RA patients predicts MTX responsiveness. We
further showed that RA patients harboring gut microbiota that quickly metabolized MTX were less likely to
respond to MTX, suggesting gut microbial metabolism of MTX contributes to response. The genes responsible
for metabolism and the causal impact of microbial metabolism on MTX pharmacology remains unknown. This
knowledge could transform our understanding of modifiable factors that affect MTX response; they could provide
a foundation for the design of therapies that modify or target the gut microbiota. Thus, we seek to test the
hypothesis that gut bacterial metabolism of MTX interferes with RA treatment. Dr. Nayak and a trainee, supported
by this administrative supplement, will investigate the following independent and complementary aims: (1)
identify gut microbial genes responsible for MTX metabolism, (2) quantify the impact of the gut microbiome on
MTX metabolism in vivo. The proposed studies will provide insight into the mechanisms by which the microbiome
affects the treatment of rheumatologic disease. Defining these mechanisms will advance our knowledge of the
role of the microbiome in precision medicine.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis is a debilitating autoimmune disease affecting over one million Americans; first-line treatment with oral methotrexate takes three months to become effective and is inadequate in 50-70% of individuals, leading to increased pain and permanent damage. Physician-scientists have tried to develop predictive tools to identify methotrexate responders, but none have examined the role of the gut microbiome. We find that gut bacteria metabolize methotrexate, and in this proposal, we aim to identify bacterial features that influence clinical response, with the long-term goal of developing predictive tools to guide therapy and identify druggable microbial targets to personalize the care of rheumatology patients.